EFFECTS OF HUMAN RECOMBINANT THROMOPOIETIN (TPO) ON GROWTH OF MEGAKARYOCYTES

The purpose of this protocol is to determine the in vitro responsiveness to TPO of platelet progenitors isolated from the cord blood of preterm thrombocytopenic infants, compared with non-thrombocytopenic preterm infants and term infants.